Cancer Center Support (CORE) Grant

The overall mission of The Jackson Laboratory Cancer Center (JAXCC) is to bring genomic solutions to cancer
medicine. We continue to develop a culture of scientific discovery, excellence, transdisciplinary research, and
collaboration to yield tangible benefits to cancer patients extending beyond the generation of new knowledge.
Our basic research goal is to tackle the question of “Genetics and Genomics of Aging and Cancer”, while our
translational intent is to contribute new concepts, technologies, and clinical education initiatives originating
from basic science to advance precision cancer medicine. The JAXCC has been supporting the basic research
of its members as well as cancer researchers at large for over 40 years by focusing on genetic models of
cancer. This history laid the groundwork for development of a precision genetics Program focused on
therapeutic resistance and bringing novel solutions to overcome it. Building on our success, our Research
Program is evolving to add the dimension of aging to further our efforts towards translating our basic cancer
research discoveries for the benefit of cancer patients. The JAXCC has 37 Program members and 22 Affiliate
members across our Center’s two research campuses, contributing to a single highly integrated Program. Our
research is supported by three interactive and complementary Shared Resources, which provide access to
cutting-edge technologies and expertise. JAXCC members are experts in varied fields converging on the
cancer problem by bringing novel approaches in a concerted, transdisciplinary manner. These approaches and
expertise include strengths in complex genetics, functional genomics, cross-species integration, and the
development of innovative animal, cellular, and computational models for studying aging and cancer. Our
organizational structure allows us to support such an integrated strategy to achieve impactful contributions that
ultimately lead to advances in precision cancer medicine.

Public health relevance
PROJECT NARRATIVE OVERALL The greatest challenges to understanding and treating cancer are its genetic complexity, cellular heterogeneity, and association with aging. Propelled by our expertise in the integration of mouse and human biology, organismal and cellular models, and advanced genomic technologies empowered by intelligent computational systems, The Jackson Laboratory Cancer Center (JAXCC) seeks to uncover the mechanisms that drive the aging-associated cellular dysfunction, chronic inflammation, and immune dysfunction that contribute to cancer. We translate our findings to the clinic through new concepts, technologies, and clinical education initiatives originating from basic science to advance precision cancer medicine.